Enhancing immunity by protecting lymphatic muscle cells from MRSA-Induced dysfunction

Recent data suggest that skin and soft tissue infections may lead to the onset of lymphedema, a debilitating and
incurable disease of lymphatic vessel insufficiency that annually affects 10 million Americans. However,
mechanisms underlying infection-driven impairment of lymphatic vessel function are not completely understood.
The overall goal of the project is to elucidate the mechanisms responsible for the sustained impairment of
lymphatic vessel contractility and lymph flow. By identifying and understanding these mechanisms, we aim to
develop targeted interventions that can restore fluid balance and boost immune function to aid in the clearance
of primary and recurrent bacterial infections.
Lymphatic muscle cells (LMCs) facilitate autonomous lymphatic vessel contraction, but our recent studies and
work from others demonstrate pathological impairment of LMC function. In Aim 1, we will use lineage tracing to
evaluate the regulation of LMCs following bacterial infection. Further, we will use single-cell RNA sequencing to
investigate whether bacteria alter the transcriptional and functional signatures of LMCs. We will also perform
calcium imaging studies to test whether LMCs exposed to bacteria or bacterial virulence factors exhibit impaired
contractility, and whether their function can be improved by existing pharmacological agents. In Aim 2, we will
test whether pharmacological inhibitors of bacterial virulence preserve lymphatic contractility, causing the
expansion of bacteria-specific T cells that protect against subsequent infections.
Through the Boston University Education, Advising and Mentoring in STEM-Medicine (BEAMS) program, we
propose to continue and expand a summer program for historically underrepresented minorities from a Boston
public high school. This program will leverage the resources, infrastructure, and expertise of Boston University
faculty members (Dr. Kelley and Dr. Dominguez) who currently lead initiatives for underrepresented high school
and college students. During their first summer in the program, participants will receive a didactic experience
focused on enhancing their understanding of scientific concepts through comprehensive lectures, problem-
based learning, and laboratory practicums. During their second summer, students will engage in immersive
research projects within Boston University laboratories, under the guidance of investigators who have shown a
strong dedication to mentoring. These experiences are designed to foster scientific literacy and readiness for
college-level science courses. Furthermore, a structured mentoring program is intended to increase the students’
likelihood of attending college and pursuing careers in biomedical research.

Public health relevance
Skin and soft tissue bacterial infections, along with the emergence of antibiotic resistant bacterial strains, pose significant challenges to public health. Our objective is to uncover the molecular mechanisms underlying compromised lymphatic vessel function during and after skin and soft tissue infections, while also understanding the relationship between impaired lymphatic vessel function and compromised immunity. Identification of these molecular mechanisms will inform novel therapeutic targets to enhance lymphatic vessel function and anti-bacterial immunity, effectively breaking the cycle of infection and lymphatic vessel dysfunction.